Genomic Insights into the Neurobiology of Cerebral Palsy

PROJECT SUMMARY/ABSTRACT
Cerebral palsy (CP) is a major neurodevelopmental disorder (prevalence 3:1000) that alters the course of
normal brain development and impairs motor function. Although both prematurity and lack of oxygen to the
developing brain are well-known causes of CP, current estimates suggest that up to one third of cases of CP
may be genetic in origin. This represents a major shift for the field, which has almost exclusively focused on
environmental contributions to date. Only a handful of genetic causes of CP are known, suggesting research in
this area may be ‘scratching the surface’ of a vast genomic landscape, comparable to that seen in other
neurodevelopmental disorders such as autism, intellectual disability and epilepsy. Although other inheritance
patterns likely lead to CP in some patients, the central hypothesis of this proposal is that for many individuals
with CP, mutations in a single gene may account for their condition.
This project unites clinicians, researchers and advocacy stakeholders in order to discover and validate novel
genetic causes of CP. The research team will employ whole exome sequencing to comb through the protein-
coding regions of the genome to find causative mutations in previously unrecognized genes relevant to CP. We
focus on individuals with cryptogenic CP (i.e. CP of unknown cause) and thus our cohort is highly enriched for
strong genetic effect sizes.
Our preliminary data indicate that deleterious mutations substantially contribute to cerebral palsy, and identify
multiple high-confidence “cerebral palsy genes.” These results suggest that although genes implicated in cases
of cryptogenic CP are diverse, many map to common pathways. The goal of this application is to extend our
preliminary findings to encompass a much larger cohort, providing the power required to define fundamental
aspects of the genetic basis of CP. Whole exome sequencing of 500 parent-child trios is proposed to
accomplish the following aims: 1) discover new genes and pathways that lead to CP when mutations occur; 2)
pinpoint genes crucial for normal motor neurodevelopment; 3) distinguish bona fide mutations from benign
DNA variants through a series of validation experiments in multiple model systems.
Impact: Successful completion of the proposed aims will allow identification of new ‘CP genes’ with immediate
diagnostic implications. These findings will also allow the construction of a genomic “roadmap” of shared
pathways connecting genetic forms of CP. In so doing, these studies will provide a window into CP
neurobiology that will compare and contrast pathways between genetic and environmental forms of CP.
Finally, this work will generate important primary data that will be shared within the recently established
International Cerebral Palsy Genomics Consortium, spearheading international collaboration in CP genomics.

Public health relevance
PROJECT NARRATIVE (PUBLIC HEALTH RELEVANCE STATEMENT) Cerebral palsy is the cardinal neurodevelopmental disorder affecting motor function. Although prematurity, oxygen deprivation, and prenatal infection are well-known causes of cerebral palsy, recent data indicates that genetic contributions to cerebral palsy are significant. The proposed studies aim to advance our understanding of the developmental neurobiology of cerebral palsy by generating a gene-based map of pathways relevant to CP; this work has the potential to improve diagnosis and inform therapeutic development for this lifelong disorder.